Seahorse XFe24 Metabolic Flux Analyzer

PROJECT SUMMARY
The application seeks support to acquire an XFe24 extracellular flux analyzer to advance research initiatives
led by six investigators from Auburn University Montgomery (AUM) and one from Tuskegee University. These
investigators are actively pursuing both NIH and NSF funding opportunities. The XFe24 is crucial for
generating highly supportive preliminary data essential for successful grant applications across diverse areas
of study. The research areas span cardio and cerebrovascular disease, cancer, adipose tissue biology,
environmental toxicology, host-pathogen interactions, basic and applied microbiology, immunology, and cell
biology. Primary users include Drs. Siva Sakamuri, David Ro, and Shivakant from AUM, supported by minor
users Drs. Douglas Leaman, Ben Okeke, Pete Haddix from AUM, and Dr. Balasubramanyam Karanam from
Tuskegee University.
The justification for acquiring the XFe24 includes: 1) Unique Equipment Capabilities: Similar equipment is
unavailable at the College of Sciences (COS) or nearby colleges or institutes. 2) Faculty Expertise: Newly
recruited COS faculty possess extensive technical knowledge, and the instrument is vital for generating
preliminary data for grant applications. 3) Research Priority: Existing COS faculty strongly prioritize
investigating energy metabolism in their established research to understand underlying mechanisms
comprehensively. 4) Educational Value: Glycolysis and Mitochondrial OXPHOS are fundamental energy
pathways integral to COS biology and chemistry undergraduate courses. The XFe24 analyzer provides
practical experience in these areas. 5) Graduate Student Training: Graduate students with Master’s
degrees in Biochemistry and Molecular Biology will receive comprehensive training in this advanced
technique, enhancing their academic and industrial competitiveness. 6) Research Impact: Research across
various areas, including aging and neurodegenerative diseases, obesity, toxicology, cancer biology, general
and industrial microbiology, host-pathogen interactions, and immunology, heavily depends on the availability
of this equipment to maintain competitiveness and achieve a strong record of scientific productivity. 7)
Collaborative Opportunities: Researchers from nearby colleges and institutions can also utilize the XFe24
analyzer as a valuable research tool, fostering collaboration and resource-sharing.
Acquisition of the XFe24 will support the immediate research needs of AUM and Tuskegee University
investigators and contribute to advancing scientific knowledge and interdisciplinary collaborations within the
region.

Public health relevance
PROJECT NARRATIVE The funding application aims to acquire an XFe24 extracellular flux analyzer to support research led by six investigators from Auburn University Montgomery (AUM) and one from Tuskegee University. These researchers depend on the XFe24 for crucial preliminary data across diverse fields, including cardio and cerebrovascular disease, cancer, and adipose tissue biology, among others, essential for their NIH and NSF funding pursuits. The instrument's acquisition not only maintains research competitiveness but also fosters collaboration, benefiting AUM and Tuskegee University and advancing scientific knowledge in the region.